Quantitative HER3 PET Imaging for Assessing Resistance and Guiding Therapy

Abstract
Aggressive forms of breast cancer, often resistant to standard chemotherapy, are increasingly treated with
targeted signaling pathway inhibitors. HER2 inhibitors are standard of care for treatment of HER2+ breast
cancer, and inhibitors of PI3K as well as AKT both demonstrate promise for the treatment of triple negative
breast cancer. While these therapies have shown improvements over traditional therapies, there are several
mechanisms that can limit response, with accumulating evidence suggesting that a dominant mechanism
limiting efficacy is the release of an intrinsic negative feedback loop that causes upregulation of the receptor
tyrosine kinase human epidermal growth factor 3 (HER3). Excess HER3 forms heterodimers with HER2
monomers (in HER2+ breast cancer) or EGFR monomers (in triple negative breast cancer) and allows for
continued growth pathway signaling. This dynamic upregulation of HER3 occurs within days of therapy
initiation, and is not the result of acquired genetic mutations, but rather an intrinsic cellular response to attempt
to maintain homeostasis. Furthermore, this pathway is variably active across patients, without any current
method of predicting its activity prior to therapy initiation. Understanding if and when this resistance
mechanism is active in a given patient started on targeted inhibitors remains clinically impractical, as it requires
invasive tissue biopsy both before therapy initiation as well as during treatment. Such paired biopsies have
associated patient-risk, and moreover a single-site biopsy does not reflect intrinsic tumoral heterogeneity. To
rapidly and noninvasively identify breast cancer patients that will develop resistance to targeted inhibitors
through increased HER3 expression and rationally guide subsequent therapeutic choices (such as HER3
inhibitors) to overcome this resistance, we propose to develop and utilize a clinically-translatable HER3 PET
imaging paradigm. To this end we have developed a first-in-class HER3 targeted peptide for PET imaging. In
the envisioned imaging paradigm patients would be imaged with HER3 PET prior to and again shortly after
starting therapy, to assess for change in tumoral HER3 expression. We will investigate this approach in both
established cell lines of HER2+ and triple-negative breast cancers. We will determine threshold levels of
HER3 expression change, as assessed by HER3 PET SUV, that are predictive of a tumor overcoming targeted
inhibition through increase in HER3 expression. We will demonstrate the ability of such imaging to predict
resistance and subsequently guide adaptive therapy by testing in patient-derived xenografts, which more
closely resemble the heterogeneity of clinical practice. This approach represents an evolution in the use of
imaging to guide therapy on a personalized basis, providing immediate insight to mechanisms of therapy
resistance and guiding alternative treatment strategies in a non-invasive manner, a major advancement over
both standard anatomical imaging or invasive biopsy.

Public health relevance
Project Narrative Aggressive forms of breast cancer, often resistant to standard chemotherapy treatment, are increasingly targeted with newer signaling pathway inhibitors, based on histologically determined molecular signatures of individual tumors. Intracellular feedback loops that regulate human epidermal growth factor receptor 3 (HER3) often allow tumors to overcome these targeted inhibitors by dynamically increasing surface HER3 expression, restoring growth pathway signaling in a process that can begin within days of therapy initiation. We propose the development of an imaging approach to assess HER3 expression changes that occur with targeted therapy regimens, allowing the rational selective addition of HER3 inhibitors in an adaptive therapy paradigm.